Angiotensin-sensitive neurons in the nucleus of the solitary tract mediate social stress induced hypertension

Project Summary
Despite therapeutic advances, ~20% of patients with hypertension have uncontrolled high blood pressure, a
condition that is associated with dysfunction in brain cardiovascular control centers. Therefore, there is a critical
need to understand the neural pathways involved in cardiovascular regulation and how their dysfunction
contributes to high blood pressure. This is particularly important for hypertension that is induced by chronic social
stress, a major problem in today’s world, which involves activation of neuroendocrine and autonomic
mechanisms. Our previous studies using novel genetic mouse models, viral-mediated gene transfer and
optogenetics have revealed angiotensin type-2 receptor (AT2R)-containing neural pathways within the nucleus
of the solitary tract (NTS) as important anti-hypertensive targets. Activation of AT2R-containing NTS neurons
[referred to as NTSAT2R neurons] elicits profound increases in blood pressure; in contrast the AT2R(s) themselves
serve a negative regulatory function, as their activation decreases blood pressure under both normal and
hypertensive conditions. Based on our findings, we have developed the hypothesis that NTSAT2R neurons are a
critical component of the neural pathways that mediate hypertension induced by chronic social stress.
Specifically, we predict that during chronic social stress their activity is driven by excitatory (glutamatergic) inputs
from the paraventricular nucleus of the hypothalamus (PVN), and that they in turn raise blood pressure via two
mechanisms: Activation of GABAergic NTSAT2R neurons, which are the largest population of AT2R containing
cells in the NTS, elicits baroreflex inhibition; Activation of Glutamatergic NTSAT2R neurons, which project to higher
order brain regions such as the PVN, increases sympathetic outflow and neuroendocrine secretion. We further
predict that selective activation of AT2R(s) present on NTS neurons will offset social stress-induced hypertension
by restoring baroreflex function and normalizing sympathetic outflow and neuroendocrine secretions. Our overall
hypothesis will be tested in three Aims that utilize a novel model of hypertension in mice (Chronic Social Defeat
Stress [CSDS]) along with genetic (e.g., optogenetic and chemogenetic) and pharmacological approaches. Aim
1: Dissecting a specific neural circuit that impinges on and regulates NTSAT2R neurons, will test the specific
hypothesis that PVN inputs to NTSAT2R neurons are necessary and sufficient to promote CSDS hypertension.
Aim 2: Investigating distinct mechanistic roles for GABAergic vs. glutamatergic NTSAT2R neurons in
regulation of blood pressure during hypertension, will test the specific hypothesis that GABAergic NTSAT2R
neurons inhibit the baroreflex, while glutamatergic PVN-projecting NTSAT2R neurons stimulate vasopressin
neurons and sympathetic outflow. Aim 3: Targeting NTSAT2R neurons to alleviate CSDS hypertension, will
test the specific hypotheses that NTSAT2R neurons are necessary for the development of CSDS hypertension,
and that these neurons or AT2R may be targeted to alleviate it. Collectively, these studies will provide mechanistic
insight that may direct development of novel therapeutics to treat hypertension induced by social stress.

Public health relevance
Project Narrative Hypertension shortens life expectancy and increases the risk for cardiovascular disease and stroke. This project examines how social adversity or the chronic relegation to low social status may impact specific brain areas to induce sustained hypertension. We hypothesize that the disruption within a specific angiotensin sensitive neural circuit contributes to high blood pressure and may therefore be targeted to treat the disease